Hydrogel Therapies for Alopecia Areata

Proposal Summary/Abstract
Candidate: Dr. Leo Wang holds a BA, MS, MD, and PhD from the University of Pennsylvania, where he is
currently completing dermatology residency and a postdoctoral fellowship. Since 2018, Dr. Wang has been
working with Dr. George Cotsarelis, MD, with a primary focus on biomaterial-based approaches for addressing
hair and skin disorders. Support from a K08 award will strategically position Dr. Wang to become an R01-funded
investigator and a leader in the fields of biomaterials and dermatology.
Environment: The mentor, Dr. Cotsarelis, is the Milton Bixler Hartzell Professor and Chair of Dermatology. He is
internationally recognized for expertise in hair disorders, animal models of skin diseases, and therapeutic
development. Dr. Cotsarelis boasts a remarkable track record as a mentor, including for previous K08 awardees.
Dr. Cotsarelis will be joined by a mentoring committee comprising experts in relevant domains. Dr. Christopher
Madl, PhD, Assistant Professor of Materials Science and Engineering, is a leading authority in hydrogel
biomaterials, who will provide expertise in synthesis, characterization, and applications. Dr. David Margolis, MD,
PhD, Gerald Lazarus Professor of Dermatology, is a world-renowned specialist in clinical trials, biostatistics, and
biomaterials for clinical translation, who will advise animal studies. Dr. John Wherry, PhD, the Richard and
Barbara Schiffrin Professor and Chair, Department of Systems Pharmacology & Translational Therapeutics, will
provide mentorship in immunologic analysis of the alopecia areata model. The K08 proposal encompasses
training in engineering, mass spectrometry imaging techniques, in vivo models, accompanied by coursework.
The University of Pennsylvania offers an outstanding Dermatology faculty, fostering opportunities for
collaboration, and boasts NIAMS P30-supported core facilities and other cores to support the proposed studies.
Research: Alopecia areata (AA) is an autoimmune disease caused by a cytotoxic T cell-mediated inflammatory
response in the hair bulb leading to nonscarring hair loss. Janus kinase (JAK) inhibitors have been approved
clinically for use, but their utility is limited by the risk of systemic toxicity, necessitating innovative delivery
methods. Injectable hydrogels offer a promising solution by enabling local and sustained drug delivery,
concentrating the medication in the skin while minimizing systemic absorption. This research proposal aims to
harness the nitrile group present in baricitinib, an FDA-approved oral JAK inhibitor, to form a dynamic covalent
thioimidate bond with a thiolated hydrogel to treat alopecia areata. The proposal will test the hypothesis that
thioimidates can sustain drug delivery for 12 weeks after injection, ensuring high local bioavailability in human
skin xenografts, low systemic absorption, and effectiveness in preventing and treating alopecia areata. This
technology has significant translational potential and can be readily utilized by dermatologists and other
healthcare providers for various skin and systemic disorders that converge on JAK signaling.

Public health relevance
Project Narrative: Alopecia areata (AA) is an autoimmune skin disease that leads to significant hair loss and is associated with both systemic comorbidities and serious impact on quality of life. Janus kinase (JAK) inhibitors are approved as oral therapies to treat AA but have off-target toxicities including clotting, heart attacks, and malignancy. The proposed research aims to utilize a novel hydrogel approach utilizing a thioimidate chemistry to localized and sustain the delivery of baricitinib, an FDA-approved oral JAK inhibitor, to alopecia areata, which has high potential to change the way alopecia areata and other autoimmune skin diseases are treated.